Generation of deletion mutants in any chlamydial species: Quick and easy!

Abstract
Members of the genus Chlamydia are Gram-negative bacteria that cause various acute as well
as chronic diseases in humans. Although chlamydiae share numerous aspects of their typical
bacterial life style, such as intracellular developmental cycle and the preference to primarily
invade epithelial cells, these human pathogens employ sophisticated species-specific strategies
contributing to an extraordinary diversity in tissue tropism and disease manifestation. C.
trachomatis infects mucosal surfaces of the human urogenital tract or columnar epithelial cells
of the eye. Chlamydia-mediated genital infections represent the leading cause of bacterial STDs
in the United States, with 1, 758,668 infections reported to the CDC in 2018. C. trachomatis
isolates are divided into 15 major serovariants. The less invasive isolates, which cause
infections of mucosal layers, include ocular serovars A, B, Ba, C, while serovars D through K
cause sexually transmitted diseases. The lymphogranuloma venereum (LGV) serovars, L1, L2,
and L3, transiently infect epithelial cells but then invade the submucosae to infect macrophages,
which facilitates the dissemination of the bacteria to the regional lymph nodes. Genetic
manipulation of C. trachomatis, L2, which has been extensively developed in the last decade,
significantly helped to elucidate how these pathogens interact with their hosts and possibly,
cause diseases. However, in order to discover and understand the mechanism(s) for chlamydia-
specific host tropism and pathogenesis outcomes with each chlamydial species, it is imperative
to expend molecular genetics technologies to all chlamydial species and strains. We propose
here, to optimize a unique, recently developed approach for generation of null mutants by allelic
exchange via homologous recombination, using pUC19 shuttle vector, that would be applicable
to any member of the genus Chlamydia. We intend to utilize this approach in production of
deletion mutants in pmpI and pmpD in C. trachomatis, serovars L2, D, and B. Moreover, the
pmpI and pmpD will be knocked out in C. mudirarum since this rodent chlamydial species is
typically employed in studies investigating chlamydial pathogenesis in vivo. Phenotypical
studies with ∆pmpI and ∆pmpD chlamydiae with their WT counterparts and complemented
strains will be conducted in various human as well as murine cells cultures in order to identify
possible species-specific and host-specific interactions.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Organisms of the family Chlamydiaceae include significant human pathogens. C. trachomatis, serovar L2, which is one of the invasive lymphogranuloma venereum strains, the noninvasive genital serovar D, and the ocular strain B and C. muridarum will be employed in generation of pmpI and pmpD null mutants by allelic exchange via homologous recombination utilizing a unique approach with pUC19 shuttle vector to demonstrate that this novel method can be applied to any chlamydial species. Phenotypical studies with ∆pmpI and/or ∆pmpD are very likely to reveal a distinctive role(s) these Pmps may play during attachment, invasion and/or development of Chlamydia.